Genomics Core

ABSTRACT. GENOMICS CORE.
The Genomics Core (the Core), was established through Phase I of Epigenomics COBRE at the University of
North Dakota and has become an indispensable resource for researchers throughout UND. The principal mission
of the Core is to guide investigators through the design, acquisition, and analysis of large-scale epigenomics
data. In addition to assisting with research projects, the Core facilitates management, storage and sharing of
large-scale data sets generated by these research projects, consistent with NIH guidelines. The Core plays a
vital role in educating the UND research community on using computational tools, incorporating big-data projects
into biological laboratories and actively supports collaborations outside of the Epigenetics group. Due to the
explosion of recent discoveries in the field of epigenomics as well as initial success of early Core supported
projects, the Core has become a key part of Epigenetics research at UND. The demand for Core’s services is
expected to increase further through the next several years. Phase II proposal builds on a solid foundation
established in Phase I by focusing on sustainability of the facility in all three aspects of our operation. In the
sequencing laboratory, there has been continuous growth of sample submission numbers. Phase II efforts will
focus on standardization of library preparation procedures, improving faculty access to sequencing options, and
developing a cost center that can support the day to day operations of the Core. The bioinformatics capabilities
will continue to grow as well by expanding compute and storage resources and offering more data analysis
pipelines as standardized services. To ensure effectiveness of our educational efforts, we will continue to
spearhead our graduate student curriculum to keep up with the latest technologies in the field, and will offer
workshops to faculty, postdocs and students across campus. These initiatives will help the Core expand its
services in research and education, lower the barriers for new users to enter the field of Epigenomics and, taken
together, will help achieve long-term sustainability of the Core and success of the Epigenetics Working Group.